MRI-guided biopsy of pelvic bone marrow edema lesions in axial spondyloarthritis

Project Summary
Subchondral bone marrow edema lesions are a characteristic magnetic resonance imaging (MRI) finding
of sacroiliitis in patients with axial spondyloarthritis (SpA). The histopathological equivalent of bone marrow
edema in axial SpA is unknown. Based on studies in rheumatoid arthritis, we hypothesize that the bone
marrow edema lesions in axial SpA represent inflammatory infiltrates. In this pilot study, patients with axial
SpA and healthy controls will undergo MRI-guided bone marrow biopsy to determine the histopathology of
bone marrow edema lesions detected on MRI and identify major immune cell subsets present in these
lesions. The results from these experiments will determine feasibility and guide larger scale investigations
into the pathogenesis of axial SpA in the future. Understanding SpA pathogenesis at the level of the
diseased tissue is a key requirement for the development of strategies to cure or prevent this disease.

Public health relevance
Project Narrative Bone marrow edema adjacent to the sacroiliac joints is a characteristic MRI finding in patients with axial spondyloarthritis. In this pilot study, we will analyze tissue obtained from patients with spondyloarthritis and healthy controls by imaging-guided pelvic bone marrow biopsy. The study will clarify the nature of the bone marrow edema lesions seen on MRI and establish feasibility and utility of bone marrow biopsies in spondyloarthritis research.